ARISEN (Autoimmunity, Rasmussen’s, Inflammation & Status Epilepticus research Network)

Administrative Core - Project Summary
The Administrative Core for ARISEN (Autoimmunity, Rasmussen’s, Inflammation & Status Epilepticus research
Network) will ensure successful completion of the aims in this proposal. The goal of ARISEN is to improve
outcomes in patients with autoimmune encephalitis (AE), Rasmussen syndrome, and NORSE (new onset
refractory status epilepticus). These are rare diseases, and thus a multi-center registry will optimize our ability
to understand the natural history, identify biomarkers, improve clinical trial readiness, and optimize treatments.
The proposed ARISEN administrative core leverages the infrastructure and prior success of two consortia: (1)
CONNECT (CONquering Inflammation and Epilepsies ConsorTium), which is the first multi-center prospective
pediatric-focused U.S.-based registry for AE and Rasmussen’s, and (2) the NORSE Institute which includes
children and adults. MPI Dr. Gombolay started and has led CONNECT with co-I Dr. Stredny experience with
handling multiple institutions’ IRBs, subaward contracts, and data use/material transfer agreements. Dr.
Gombolay also has assembled a large multicenter retrospective study that is the largest pediatric anti-NMDA
receptor encephalitis (anti-NMDARE) database to date with data from 17 institutions on 298 children under 18
years of age diagnosed with anti-NMDARE. Dr. Murray (MPI) started collaborating with Dr. Gombolay in 2022
and supervised the collection of data for this study from Texas Children’s Hospital, her prior institution before
joining Emory and CHOA as the new Chief Research Officer in April 2024. Drs. Gombolay and Murray will also
draw on the experience from Dr. Clardy, PI of the multicenter U01 ExTINGUISH trial through NeuroNEXT, and
Dr. Hirsch, PI of the multicenter NORSE registry. This team of strong leaders has the expertise to achieve the
goals of this proposal. The ARISEN Administrative Core will provide oversight, coordination, and logistical
support for the successful operation of the ARISEN registry. We have carefully selected a network of 24 sites
that individually and synergistically provide experience within these diseases, along with a complementary
breadth of expertise to effectively and comprehensively address the aims of ARISEN. Both CONNECT and
NORSE have demonstrated successful recruitment of patients for biorepository research. Emory has provided
scientific, regulatory, biostatistical, laboratory/ biorepository and data management support among the sites.
The Administrative Core will promote a cohesive and inclusive network within ARISEN and patient advocacy
groups (PAGs) (Aim 1) and will facilitate communication among all the sites, the External Advisory Committee,
and key stakeholders from the PAGs (Aim 2). One of our PAGs will distribute the patient enrollment fees to the
sites. The Administrative Core will provide effective support of the ARISEN Registry including maintaining the
ARISEN registry’s website and overseeing the research projects along with input from the External Advisory
Committee. The core will work closely within the Rare Disease Clinical Research Network (RDCRN) and with
the RDCRN Data Management and Coordinating Center (DMCC).